1,4-DIHYDROXY-2-NAPHTHOYL-COA SYNTHASE IN COMPLEX WITH HIGH AFFINITY SUBSTRATE A

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. MenB is in the center of the biosynthetic pathway converting chorismate into menaquinone, which is required for electron shuttling in lipids in the anaerobic respiration process of Mycobacterium tuberculosis. Inhibitors targeting MenB and therefore menaquinone biosynthesis can potentially be used for treating latent TB since respiration is expected to be necessary even in the dormant state. Most developing drugs are targeting the active form of TB but the latent form remains a great concern. We have developed inhibitors with moderate affinity for MenB and structures obtained here will be used for rational design of inhibitors with improved activities.